Mechanics of Hearing Workshop - 2024

Abstract
We request partial support to cover the expenses of the 15th Mechanics of Hearing (MoH) Workshop, to be held at the
University of Michigan in Ann Arbor, MI in June 2024. Since their inception in 1983, the Mechanics of Hearing Workshops
have provided the primary forum for presenting, debating, and sparking advances in the fields of auditory biomechanics and
biophysics. Convened at three-year intervals, the Workshops bring together researchers working on the mechanics of
hearing for nearly a week of intense discussion. The Workshop will create bridges between numerous scientific fields and
approaches by covering auditory biophysics at the molecular, cellular and system levels with both experimental and
theoretical approaches and aims to advance our understanding of the mechanics of hearing. As it has in the past, this
Workshop seeks to offer an invaluable opportunity to graduate and post-doctoral trainees to discuss their work, develop
new ideas, interface directly with more senior scientists, and absorb the practice and sociology of science. The intentional
opportunity for formal and informal interaction between junior and more senior investigators is a memorable hallmark of this
Workshop. Attendees are from a wide range of U.S. and international institutions, and the Workshop has historically been
held at both domestic and international locations. The most recent Workshop was held in Denmark. Prior to that, Workshops
were held in the Netherlands, United Kingdom, Japan, Germany, Greece, Canada, and the United States. The University
of Michigan was chosen because of its central location (allowing easy travel for the majority of the participants), outstanding
conference facilities and support services, idyllic campus/surroundings, and very reasonable costs. In this proposal, we
request funds from the NIH to cover student and post-doctoral travel awards, travel of invited speakers, and a portion of the
audio-visual costs (including CART/captioning services).

Public health relevance
Project Narrative: Deafness is the most common and arguably the most socially isolating sensory impairment, with the World Health Organization estimating that over 360 million people worldwide have moderate to profound hearing loss. Although the physiological causes of most forms of deafness are incompletely understood, it is clear that changes to the delicate structures of the peripheral auditory system, such as the cochlear hair cells normally responsible for the high sensitivity and exquisite frequency selectivity of hearing, are mostly to blame. A deeper scientific understanding of peripheral auditory function at both the structural and molecular level therefore remains critical to reducing the devastating impact of hearing loss on both individuals and society.